The anatomy of T-cell mediated neutrophil recruitment during lung infection

Abstract
Pneumonia is a leading cause of morbidity and mortality worldwide. Microbes that cause respiratory infections
are encountered by virtually everyone, but effective immunity in healthy individuals typically prevents such
exposures from progressing to pneumonia. Yet, host signals guiding lung defense constitute a major
knowledge gap, limiting opportunities for clinical intervention in patients at risk for pneumonia. A goal of our
research is to delineate when, where, and how prior experience with respiratory pathogens influences
pneumonia susceptibility thereafter. Recovery from lung infections elicits strong and rapid protection in
response to a subsequent challenge with related but distinct organisms (e.g., different strains/serotypes). We
and others have demonstrated that this heterotypic protection is location-dependent, restricted to the
previously exposed region and independent of circulating factors. Moreover, accelerated immunity in
experienced lungs requires lung CD4+ resident memory T (TRM) cells, which accumulate in the interstitium
near bronchovascular bundles and pulmonary veins. CD4+ T cells are required for the rapid and protective
neutrophil response observed in experienced lungs, and our pilot studies, using a novel crystal ribcage
approach to connect experienced lungs to the circulation of naïve mice, indicate that this is specifically driven
by lung-localized CD4+ TRM cells. Excitingly, this same approach revealed neutrophil recruitment as remote as
subpleural alveoli in as few as 4hrs in the experienced lung, demanding a better understanding of the multi-
cellular signaling network tethering CD4+ TRM cells to enhanced neutrophilic defense. The primary objectives
of this proposal are to determine the spatiotemporal relationship between centrally concentrated CD4+ TRM
cells and emigrated neutrophils during pneumonia, while developing a transcriptional atlas of key immune
processes corresponding with enhanced defense in the experienced lung. To do so, we will test the
hypotheses that: 1) Infection of the experienced lung activates CD4+ T cells in the interstitium of
bronchovascular bundles and pulmonary veins, coinciding with diffusely parenchymal neutrophil recruitment;
and 2) CD4+ T cells in the experienced lung trigger rapid, diffuse, and heterogeneous transcriptome changes
across diverse distal lung and immune cells. This will be accomplished using state-of-the-art approaches for
imaging, cytometry, and spatial transcriptomics, leveraging expertise and resources across two neighboring
institutions. Results from this study will provide key insights about the cells and signals dictating host immunity.
Furthermore, data from the proposed experiments will provide a foundation for future investigations by our
groups and others, having a lasting impact on the field.

Public health relevance
Project Narrative Pneumonia is a public health crisis, representing the world’s greatest burden of disease and the leading cause of infection-related deaths. While virtually everyone encounters the major organisms that cause pneumonia, effective immunity typically prevents the onset of pneumonia in healthy individuals. The major goal of this proposal is to determine multi-cellular networks through which prior immune experience enhances respiratory defense.